Understanding the mechanism of tropism specific immune restriction in HIV infection

1 PROJECT SUMMARY/ABSTRACT
2 HIV/AIDS remains a significant public health issue, with an estimated 39 million individuals currently living with
3 HIV globally, of whom only 76% are on combination antiretroviral therapy (cART). cART suppresses, but does
4 not eliminate, HIV and is associated with its own burden of lifelong treatment. Thus, there is a pressing need
5 for research to advance the field towards a novel cure for HIV. In the proposed research study, we aim to
6 address this through a unique perspective, by focusing on how the human immune system naturally restricts a
7 specific subset of HIV. HIV tropism is defined by coreceptor use after initial CD4 binding by the virus envelope
8 protein. During the early clinical stages of HIV infection, a subset of HIV which uses the CCR5 coreceptor,
9 termed R5-tropic virus, is dominant, while another HIV subset which uses the CXCR4 coreceptor, termed and
10 X4-tropic virus, is restricted and does not emerge until progression to late clinical disease stages, when the
11 immune system has been impaired. We propose to identify the molecular mechanisms that control the natural,
12 immune-mediated restriction of X4-Tropic virus. Using primary CD4 T cells, in vivo analyses in humanized
13 mouse models, experimental knockout of candidate genes, and analyses of banked patient specimens that
14 predate the widespread use of cART, the candidate will (1) characterize the molecular mechanisms that drive
15 restriction of X4-Tropic viral replication in the presence of R5-Tropic virus, and (2) characterize the mechanism
16 underlying the emergence of X4-Tropic virus during the late clinical disease stages. The overall goal of the
17 proposed study is to gain an understanding of how our immune system naturally restricts X4-Tropic viral
18 replication and how this restriction is lost in late-stage disease. This knowledge will be foundational to future
19 studies that will aim to develop novel treatments for HIV that empower the immune system to restrict R5-tropic
20 virus during early clinical stages in the same manner in which it naturally restricts productive X4-tropic viral
21 replication. The enclosed proposal includes a five year career development plan which focuses on improving
22 knowledge and skills related to the study of immune mediated restriction of X4-tropic viruses and includes a
23 comprehensive mentoring and didactic plan that will ensure the candidate’s successful transition to an
24 independent career in basic and translational HIV research focused on the host-pathogen interface. The
25 candidate is supported by expert mentors and has committed institutional support, with a promotion to
26 Instructor planned prior to the commencement of the K08 award period and 75% research time protected
27 during the award period. The proposed mentorship team, including a primary mentor who is a renowned HIV
28 researcher with prior experience in identifying novel immune mechanisms of HV reservoir clearance, will
29 support the candidate in developing key knowledge and skills. Successful completion of the proposed K08
30 training goals and specific aims will maximize the candidate’s chances of success in an independent research
31 career.

Public health relevance
PROJECT NARRATIVE Efforts to develop a cure for HIV have been hindered by HIV’s rapid mutational rate and ability to evade immune pressure. During the early clinical stages of HIV infection, a specific subset of HIV, X4-tropic viruses, are naturally restricted by the innate immune, while R5-tropic viruses replicate freely. In the proposed study, we will investigate the molecular mechanism that mediate this differential viral restriction using banked patient samples, in vivo mouse models, and ex vivo primary human cell analyses, with the goal of generating foundational data for the future development of novel therapeutics that empower our immune system to clear R5-tropic viral infections.